Anti-inflammatory actions of a novel hemin-induced electrophile in Sickle Cell Disease

Sickle Cell Disease (SCD) is the most prevalent genetic blood disorder in the US affecting an estimated
1 in 365 African Americans and 1 in 16,300 Hispanic Americans. SCD is associated with decreased life
expectancy and significant physical and psychological morbidity due to complications arising from recurrent
vaso-occlusion and hemolytic anemia. The activation of TLR4 by hemoglobin-derived products is a central
component of a pernicious inflammatory cascade that involves endothelial activation, formation of multicellular
platelet/neutrophil/erythrocyte aggregates and oxidative stress. The effects of SCD on kynurenine metabolism
and in particular, on the generation of a novel bioactive kynurenine-derived metabolite were hitherto
unappreciated. The bioactive kynurenine-derived mediator discovered herein activates Nrf2-dependent
expression of antioxidant enzymes and inhibits NF-κB regulated inflammatory signaling as well as abrogates
NLRP3 inflammasome activity. Formation of the bioactive kynurenine metabolite is upregulated in steady state
in both mouse models and human SCD patients, and preliminary data suggests that levels are further
increased by hemin, a critical mediator of vaso-occlusive crises (VOC) and organ injury. By inhibiting NF-κB-
dependent responses and downregulating the NLRP3 inflammasome, this novel kynurenine-derived compound
has the potential to act as an endogenous anti-inflammatory mediator capable of regulating endothelial,
platelet and immune cell activation to attenuate VOC. Furthermore, Nrf2 activation is known to be protective in
SCD via inhibition of pro-inflammatory signaling, upregulation of the heme-catabolizing enzyme HO-1, and by
increasing endogenous antioxidant defenses that scavenge reactive species. By utilizing relevant primary cell
culture systems derived from animals bearing key pathway deletions, a clinically relevant SCD transgenic
mouse model, highly specific LC-MS/MS strategies and state-of-the-art quantitative fluorescence intravital lung
microscopy, the research plan will establish the mechanisms behind the anti-inflammatory actions of the
bioactive kynurenine metabolite and its potential to attenuate vaso-occlusion in vivo. The present application is
built on solid biochemical foundations, and applies critical biological and analytical tools to successfully
transition from in vitro chemistry to translational science with the ultimate objective of positively impacting
human health. The knowledge gained from this research plan will be of pivotal importance for generating solid
preliminary for future R01 applications aimed at better defining the pathophysiological role of the kynurenine-
derived bioactive metabolite in SCD as well as in other hematological and non-hematological conditions in
which chronic inflammation, oxidative stress and ischemic organ injury are involved.

Public health relevance
The research plan is relevant to public health because it explores a novel pathway that induces an endogenous protective molecule that can be harnessed to limit inflammation and tissue in Sickle Cell Disease. Patients with this disease suffer from a chronic inflammatory state that renders them susceptible to vaso-occlusive crises, which in addition to pain, can result in life- threatening acute and chronic conditions that decrease their quality of life and shortens their life expectancy. Thus, this proposal is significant to the NIH mission in that it seeks to apply fundamental knowledge to enhance health, lengthen life, and reduce illness and disability.